Solid Phase Microextraction as a New Tool for Quantifying Antibody Drugs in Breast Cancer and Building PK-PD models

Modern drug analysis techniques are an integral part of research and healthcare today. Regrettably,
the current approach for sample collection consists of literally removing “a piece of the patient or experimental
animal” (whether it is a blood sample or a tissue biopsy) that is sent to the laboratory for analysis. Such a
procedure poses ethical issues, health risks for the medical personnel, and inconvenience for the investigated
being (patient or lab animal). Furthermore, although it has been recognized that tissue concentrations are
more predictive of clinical outcome than plasma concentrations, the assessment of drug distribution and
target site pharmacokinetics is very difficult because of lack of appropriate methodology. Point-of-care
devices for measuring electrolytes, cardiac markers, and several small molecules now reside in emergency
rooms and even at patient bedsides - but there are no clinical devices for fast monitoring of drug levels in
body fluids and tissues. The need for such devices is even greater for difficult to treat diseases such as
neoplasms.
In response to the current challenges faced by drug analysis for pharmacokinetics, pharmacodynamics,
and therapeutic drug monitoring, we are proposing to apply innovative microsampling approaches to measure
therapeutic antibody concentrations in the tumors without collecting a physical sample from the investigated
organism. These methods feature reliable calibration, freedom from pumps, no osmotic effects, and
significant improvements in sensitivity. Furthermore, they are faster and more economical than classical
ones.
The new methods will be applied for the first time to measure the tumor concentration of immune
checkpoint inhibitors that act by blocking the programmed cell death receptors on T cells.
The proposed research will utilize biocompatible sampling devices for direct microextraction of
antibody drugs from tumors. These devices will be prepared by covering flexible medical-grade metal wires
with biocompatible polymers and high affinity extractive phases. The extracted analytes will be quantified
by chromatography and mass spectrometry to offer high specificity and low limits of detection.
For quantitation, several calibration methods will be applied, such as external standard, diffusion-based
calibration, and kinetic calibration. The data will be used to build a pharmacokinetic-pharmacodynamic model
for a representative therapeutic antibody, such as pembrolizumab.
The new in vivo sampling method will be validated by comparison with large pore microdialysis. It is
expected that microextraction will provide better sensitivity, accuracy, less tissue damage (due to smaller size),
portability, and convenience (no pumps and fluids).

Public health relevance
We are proposing to create new miniaturized sampling devices that are specifically designed for measurement of drugs at their site of action. The proposed microextraction-based techniques will be used to analyze antibody drugs in the body (and tumors), alleviating the need for blood draws and biopsies. This research will expand our understanding of medicinal drugs and will facilitate the correct determination of therapeutic drug doses – ultimately increasing the safety of medication for all age groups.